AL-MedLit: an active learning collaborative platform for biomedical literature classification and model evolution

Project Summary
The goal of this application is to support Lei Wang, Ph.D., as a Research Scientist and Research Software
Specialist at The Ohio State University. He will collaborate with Dr. Lang Li and develop an active learning
collaborative platform for language models to support several NIH-funded research programs (R01LM014199,
P30HD106451, and U01CA248240). The proposed AL-MedLit platform is the first software that allows
language models and human experts to collaborate, ensuring the improvement of knowledgebase
development and reduction of the curation cost. The innovative algorithms, including both conventional
uncertainty sampling schemes and novel sampling schemes such as positive sampling, negative sampling,
and sample calibration, will be implemented in the platform to facilitate the evolution of language models. This
Research Software Engineer award would allow 3 years of funding to fully maintain Dr. Lei Wang’s dedicated
efforts toward developing an innovative active learning platform for pharmaco-informatics research programs.
In particular, he will expand his skill set, especially in the rapidly evolving fields of natural language processing
and artificial intelligence and its applications in pharmaco-informatics research. Results will be broadly
disseminated through local and national meetings as well as peer-reviewed journal manuscripts.

Public health relevance
Project Narrative Dr. Lei Wang collaborates with Dr. Lang Li and supports serval NIH-funded pharmaco-informatics research programs. His work has significantly contributed to translational research in pharmaco-informatics and clinical pharmacology. Support from this award will allow him to continue his efforts to facilitate biomedical knowledgebase development by leveraging state-of -the-art artificial intelligence and language models.